A splicing-generated protein of hepatitis B virus in chronic viral infection

Abstract
Chronic infection with hepatitis B virus (HBV) is a leading cause of liver cancer. The large (L)
envelope protein interacts with core particles to initiate virion formation, and inhibits small (S) envelope
protein secretion as subviral particles. In addition, L protein on virion surface binds to high-affinity HBV
receptor to mediate viral entry. The polymerase (P) gene has its 5' end overlapping with 3' core gene,
leading to much less P than core protein translation from the 3.5-kb pgRNA. The slightly longer pcRNA
generates hepatitis B e antigen (HBeAg). Splicing of the 3.5-kb RNAs to remove a 0.5-kb intron causes
frameshift to convert core protein into core-P fusion protein, and P protein into P-L fusion protein (p43).
Low level of p43 was detected from in vitro transfection with cloned HBV genome, but it has not been
further studied. We accidentally detected high level of extracellular p43 from artificial mutants with lost L
protein expression, with further increase to the level of L protein from wild-type virus when combined
with a nonsense mutation in core gene. This R01 grant application will investigate the regulation of p43
translation, stability, and examine its clinical significance and functional properties. We hypothesize that
preferential translation of core-P fusion protein from spliced 3.5-kb RNA down regulates p43 at both
translation initiation and protein stability, and that p43 can promote HBV virion secretion but reduce
viral infectivity. Aim 1 will verify whether p43 is preferentially translated from spliced pgRNA or pcRNA,
and clarify whether the nonsense mutation in core gene increases p43 through translational
termination-reinitiation and/or lost expression of a p43 destabilizer. We will also examine whether p43
secretion is independent of S protein co-expression. In Aim 2 we will examine whether p43 protein level
can be increased by core promoter mutations to augment pgRNA transcription, G1896A precore
nonsense mutation to abolish HBeAg expression, and Q182* nonsense mutation in core gene to
convert both core protein and core-P fusion protein into a slightly shortened core protein. p43 will also
be monitored from viremic serum samples harboring such mutations. Aim 3 will determine the
distribution of p43 on virions vs. subviral particles. A role of p43 in modulating HBV virion secretion and
viral infectivity will be verified by blocking its expression through mutated splicing sites, followed by
adding back increasing doses of p43 through co-transfection experiments. So far all the seven known
HBV proteins are translated from unspliced RNAs. The proposed studies are significant in
characterizing the only viral protein generated by RNA splicing, and in establishing its clinical relevance
and functional properties. If p43 can inhibit HBV infectivity in a dose-dependent manner, that may open
up a new antiviral approach against chronic HBV infection.

Public health relevance
Project narrative We recently found that certain point mutations to prevent expression of hepatitis B virus large envelope protein markedly increased polymerase-large envelope fusion protein, a product of RNA splicing. We will investigate whether this protein can also be increased by naturally occurring mutations selected at the late stage of chronic HBV infection, and establish its functional properties.